Changes in actin dynamics regulated by villin and gesolin are determinants of cell fate and may be key to gastrointestinal inflammatory disease

Regulation of mRNA translation is one of the most immediate cell response to any form of stress. It is initiated
by stress sensing kinases, all of which phosphorylate the alpha subunit of eukaryotic translation initiation factor
2 (EIF2A). This results in repression of global protein synthesis but is accompanied by selective translation of
proteins vital for cell survival and recovery from stress. To restore cellular homeostasis and to reverse EIF2A
signaling, de-phosphorylation of EIF2A is regulated by protein phosphatase 1 (PP1) in complex with one of its
regulatory subunits and globular actin (G-actin). G-actin therefore, limits PP1 activity although how cellular actin
dynamics are modified to regulate PP1 activity is not known. EIF2A signaling increases translation of activating
transcription factor 4 (ATF4) to promote expression of genes involved in stress remediation such as autophagy
genes. Conversely, if the stress is unresolved ATF4 regulates the transcription of genes that promote cell death
to eliminate damaged cells. The control switch that modulates the cells stress response between survival and
death governs the initiation of most inflammatory diseases. In line with that, chronic activation of EIF2A signaling
is associated with mucosal inflammation in patients with Crohn’s disease (CD). Despite this, the molecular basis
of EIF2A signaling in intestinal epithelial cells (IECs) remains unidentified. We made the novel observation that
the IEC actin cytoskeleton fulfils a general function as a biosensor of cell health and regulates EIF2A signaling
to establish if the stressed cell will survive or die. We show that by regulating cellular actin dynamics, two
homologous actin-severing proteins villin1 and gelsolin integrate stress signaling pathways with cell fate
pathways. Using the villin1/gelsolin double knockout mice we show that when the crosstalk between the IEC
actin cytoskeleton and EIF2A signaling does not function properly, chronic inflammation ensues. As a result,
DKO mice develop spontaneous ileitis that resembles functionally, histologically and clinically human CD.
Moreover, our studies with mouse models of CD and CD patient samples indicate that defects in the crosstalk
between IEC actin cytoskeleton and EIF2A signaling could be a universal feature of CD. We propose that
studying how these pathways normally function in the IECs and how they go awry can provide basic insight into
events that drive CD pathogenesis but can also identify novel treatment strategies for CD. We present an
innovative mechanistic approach using state-of-the-art techniques that combine the use of IEC lines, transgenic
and validated mouse models of disease, and patient samples. The goal of the study is: (1) to characterize the
molecular mechanism(s) by which the crosstalk between the actin cytoskeleton and stress signaling determines
IEC fate; (2) to determine how defects in the crosstalk between actin cytoskeleton and stress signaling contribute
to CD pathogenesis; (3) and to test in vivo and ex vivo in enteroids from mouse models of CD and CD patient
samples, the therapeutic benefits of targeting these defects. Our study will advance scientific discovery and
could lead to translation of the basic science to model novel therapies to advance CD patient care.

Public health relevance
Project Narrative The incidence and prevalence of Crohn’s disease (CD), a chronic, relapsing inflammatory bowel disease is rising in all ethnic and age groups and as many as 70,000 new cases are diagnosed in the US each year. The majority of CD patients are young, making it a costly lifelong disease resulting in close to $3 billion in annual healthcare costs in the US alone. Patients with CD are also at risk for early small intestine and colorectal cancer. Current treatments of CD are expensive, associated with significant side effects and induce remission in only a little over half of the patients. What causes CD remains poorly understood and the treatment approaches for CD are limited. This study will advance our understanding of what drives CD pathogenesis and could lead to translation of the basic science to model novel therapies to improve CD patient care.